Mechanistically-oriented therapy for a progressive myoclonus epilepsy

PROJECT SUMMARY
Progressive myoclonus epilepsy type 7 (EPM7) is due to a recurrent pathogenic variant in the gene KCNC1,
which encodes the voltage-gated potassium (K+) channel subunit Kv3.1. EPM is a class of devastating
conditions defined by onset of tremor, seizures, and ataxia in a previously normal child or young adult, with
relentless deterioration to wheelchair dependency as well as epilepsy and myoclonus. Further research is
required to clarify the functional role of Kv3 channels in normal brain function and how genetic variation in KCNC1
leads to EPM7 and other forms of neurological disease, so as to facilitate progress towards novel therapies,
preventative measures, or cure. Such insights may prove generalizable to other forms of EPM, which remains a
class of untreatable and incurable disorders.
This 5-year collaborative application employs a comprehensive approach and newly-generated tools to test the
hypothesis that the clinical phenotype of EPM7 is due to loss of Kv3.1 function, leading to the selective
dysfunction of Kv3.1-expressing fast-spiking neurons in discrete locations throughout the brain. Targeted
pharmacologic modulation of Kv3 channels with a potent, specific Kv3 activator will recover cellular and synaptic
abnormalities of Kv3.1-expressing neurons, leading to decreased susceptibility to seizure and improvement in
cerebellar dysfunction in an experimental model of EPM7.
Proposed experiments will determine the relationship between specific KCNC1 variants, physiology, and clinical
phenotype (mild intellectual disability with/without epilepsy; EPM7; or severe early-onset myoclonic epileptic
encephalopathy) in a large cohort of human patients with KCNC1-related neurological disorders compiled by the
applicant. To link KCNC1 variants to ion channel dysfunction, we will compare the biophysical properties of
normal Kv3 K+ channels to channels containing variant Kv3.1 subunits, as well as the ability of a novel Kv3-
specific pharmacological agent to normalize pathological channel activity (Aim 1). The impact of variant KCNC1
on the intrinsic excitability and synaptic and circuit function of Kv3.1-expressing neurons will be pursued using a
new mouse model of EPM7 generated by the applicant (Kcnc1-R320H/+ mice, which recapitulate the core clinical
phenotype seen in humans) (Aim 2). Then, we will attempt to ameliorate disease pathology via administration
of targeted therapeutics in vivo (Aim 3).
Results will provide novel information as to the role of Kv3.1 in cellular, synaptic, and circuit function and define
the pathogenic mechanisms of KCNC1-related neurological disorders towards development and implementation
of novel, targeted therapies in human patients.

Public health relevance
PROJECT NARRATIVE The progressive myoclonus epilepsies (EPM) are a class of genetically-determined neurological disorders defined by onset in previously healthy individuals of tremor, seizures, and ataxia, advancing relentlessly to loss of ambulation, chronic epilepsy and myoclonus, and early death. EPM is without cure or disease-altering treatment, yet advances in neurogenetics may inform novel therapeutic approaches. Here, we have generated a new experimental animal model of an EPM and propose to define cellular and circuit mechanisms of disease and treat the disorder using targeted pharmacotherapy that may be translatable to the clinical arena.